Claims-based measures of care coordination and long-term health among older women with endometrial cancer

Abstract
By the year 2030, the number of U.S. women with an endometrial cancer history is expected to exceed 1
million. The care needs of older endometrial survivors include not only regular follow-up visits for detection of
cancer recurrence, but also the prevention and management of other non-cancer medical conditions.
Cardiovascular disease (CVD) may be of especially critical concern, given the role of obesity as a shared risk
factor for both endometrial cancer and CVD. Care for non-cancer conditions, as well as general preventive
care and management of side effects of cancer treatment, is likely to require the involvement of primary care
physicians or other specialists, in addition to the gynecologists and/or gynecologic oncologists who may
perform the recommended follow-up exams for detection of endometrial cancer recurrence, but may not have
the expertise to manage other medical conditions. The resulting complexity of healthcare needs for
endometrial cancer survivors may lead to fragmentation of care, suboptimal care quality, and, ultimately,
poorer health outcomes. Strategies to improve surveillance and management of CVD and other chronic
conditions during survivorship, while also ensuring that women receive the recommended follow-up visits
specific to their cancer history, are needed to support the complex health needs of endometrial cancer
survivors.
Care coordination refers to efforts to organize patient care activities between two or more providers involved in
the patient’s care to facilitate the appropriate delivery of health care services. Measures of care coordination,
which model shared patient networks by connecting physicians with common patients, have been developed
using administrative claims data, and have been validated as a means of accurately representing provider
communication patterns. We propose to utilize the Surveillance, Epidemiology, and End Results (SEER)-
Medicare linked data resource to examine associations between claims-based measures of care coordination
and long-term health outcomes after endometrial cancer. Specifically, we will assess whether higher degrees
of care coordination during years 1-3 after endometrial cancer diagnosis are predictive of greater adherence to
guideline-recommended follow-up for detection of endometrial cancer recurrence, lower risk of CVD
diagnoses, lower risk of hospitalizations and emergency department visits, and higher overall survival. This
research will inform the development of targeted interventions that seek to enhance the delivery of endometrial
cancer survivorship care and improve patient outcomes.

Public health relevance
PROJECT NARRATIVE Endometrial cancer survivors are a rapidly growing population with complex healthcare needs. Coordination of care between oncologists, gynecologists, primary care physicians, and other specialists may help to ensure that survivors receive the appropriate healthcare services to improve their long-term health. Our study will investigate whether greater care coordination after endometrial cancer is associated with several critical health outcomes, and will inform the development of interventions that seek to enhance the delivery of survivorship care.